Molecular Analysis of Uterine Receptivity

Project Summary

Embryo implantation failure is a significant causal factor of infertility for women worldwide. Although advances
in our understanding of oocyte and embryo development have improved pregnancy success rates, these rates
remain unacceptably low due in part to an endometrium that is nonreceptive to the embryo. For successful
implantation, endometrial receptivity and subsequent decidualization requires coordinated progesterone (P4)
signaling in a cell-­type specific manner. While the signature cellular events that underpin P4-­driven uterine
receptivity and decidualization are known, our knowledge of the pivotal mediators of P4 action in these
processes is incomplete. This knowledge-­deficiency is significant as nothing short of identifying the key early
signals that underpin P4-­driven uterine receptivity will address the current clinical limitations in diagnosing and
treating a non-­receptive uterus at the molecular level. To address this deficiency, we recently demonstrated
that the promyelocytic leukemia zinc finger (PLZF) transcription factor is a direct target of the progesterone
receptor (PGR) and is indispensable for P4-­dependent decidualization of cultured human endometrial stromal
cells (hESCs). As further translational support for a P4 mediator role for PLZF in the human endometrium,
PLZF expression levels in human endometrial biopsies are significantly induced during the P4-­dominant
secretory phase of the human non-­conception menstrual cycle. In the early pregnant mouse, Plzf is induced in
the epithelial and stromal compartments of the receptive uterus and is strongly expressed in decidual cells with
pregnancy progression. These findings support our hypothesis that PLZF (and its downstream transcriptional
program) acts as a pivotal mediator of P4-­dependent uterine receptivity and decidualization and does so in an
endometrial cell-­type specific manner. This hypothesis will be tested by three specific aims. Using a recently
generated mouse model carrying a Plzf conditional allele, Specific Aim 1 will establish the in vivo importance
of Plzf (and its transcriptional programs) in P4-­dependent endometrial receptivity and decidualization.
Dissecting the individual contributions of epithelial and stromal Plzf signaling in the murine endometrium during
the periimplantation period will be a major focus of Specific Aim 2. We recently demonstrated that direct
transcriptional repression of the early growth response 1 (EGR1) transcription factor by PLZF is required for
hESC decidualization;; blocking this regulation impairs hESC decidualization. Prior to decidualization, however,
EGR1 in pre-­decidual hESCs is required for these cells to decidualize, suggesting that EGR1 “primes” the pre-­
decidual hESC for decidualization. Specific Aim 3 will address this proposal by molecularly characterizing the
P4-­PGR-­PLZF-­EGR1 regulatory axis that is required for in vitro and in vivo decidualization. These aims will
use state-­of-­the-­art engineered mice to study the role of Plzf in endometrial receptivity and decidualization as
well as high throughput genome-­scale approaches to identify novel endometrial targets directly regulated by
Plzf and the transcriptional interactome through which this regulation occurs.

Public health relevance
Project Narrative Implantation failure based on a non- receptive uterus is a significant reproductive health issue for which diagnostic and therapeutic treatment options are limited. This project will establish that the promyelocytic leukemia zinc finger transcription factor is a novel signal that directly mediates progesterone- dependent endometrial receptivity and decidualization, cellular processes required for early pregnancy establishment. Because of the strong clinical relevance of this project, outcomes from these studies promise to expand the scope of infertility management for those women at high risk for early pregnancy failure.